ADIPOSE TISSUE RENIN/ANGIOTENSIN SYSTEM IN LEAN AND OBESE NORMAL/HYPERTENSIVES

This protocol represents completion of work performed by our previous MCAP. No patients were admitted during this reporting period. The protocol utilized the biostatisticians for analysis and interpretation of data, and preparation of manuscripts.